14th International Workshop on HIV & Aging

Project Summary
Due to the success of antiretroviral therapy (ART), people living with HIV (PLWH) are now
experiencing life expectancies similar to those of people without HIV (PwoH), and accordingly
living into older ages. Numerous aging-related diseases are now occurring in PLWH and there is
abundant evidence that these occur at earlier ages (chronologically) than in the general
population or in demographically similar PwoH. This earlier occurrence has posed a major
problem in the clinical care of PLWH- both in understanding what the optimal care is, and in
providing clinical settings in which it can be delivered. These are major problems worldwide, but
especially in resource-limited settings. While large meetings are important venues for scientific
exchange regarding the latest knowledge concerning the care of PLWH as they age, there is a
compelling need for smaller meetings that facilitate the personal discussions and networking that
are critical to effective dissemination of advances and to the career development of early-stage
investigators in the field of HIV and aging. The International Workshop on HIV & Aging has
addressed this important need annually since 2010, bringing together 150-200 international
delegates to discuss the latest findings and controversies in the biology of aging as it is affected
by HIV and in methods for incorporating these into the delivery of clinical care to often challenging
populations. The Workshop has traditionally been held in one site over two days (although this
went to a 3-day virtual format because of the COVID-19 pandemic), with expert plenary speakers
either from pertinent areas outside of HIV research or performing research or care on PLWH, and
oral and poster presentations based on submitted abstracts. Also included are interactive panel
discussions with audience involvement; short talks dealing with topical issues in these areas, and
guided tours of related posters. Researchers receive ample feedback and evaluation on their
work. This R13 application proposes the following aims to enhance the 14th International
Workshop on HIV & Aging, which will be held on Oct. 26-27, 2023 in Washington, DC, USA:
1) To provide scholarships to trainees and investigators who need financial support in
order to attend the Workshop, especially those from resource-limited settings; and 2) To
provide support for experts from resource-limited settings to give plenary lectures at the
Workshop. Funding of this application will greatly enhance the diversity and geographic reach of
the attendance at the Workshop, which in turn will facilitate dissemination of expertise and
experience globally and translation of research findings into clinical strategies that can improve
the lifespan and healthspan of PLWH now and for years to come.

Public health relevance
Project Narrative The International Workshop on HIV & Aging is a unique forum for scientific exchange on improving the clinical care of the increasing number of people aging with HIV. We propose to enhance the 2023 Workshop by providing scholarships to early stage investigators and investigators and speakers from low and middle income countries.